Administrative Core

Administrative Core: Summary
The IPR Administrative Core has two main goals: (i) to provide essential support to the Development Core; (ii)
to maintain infrastructure that is crucial to IPR's day-to-day functioning. The Core is designed to accomplish its
two goals with a minimum of staffing and related expenses, thereby freeing maximum resources for more
direct investment in population science research. The Core is directed by IPR Director Casterline and has two
full-time staff members (Office Manager and Grants Manager), one part-time staff member (Research
Scientist), one GRA, and one or two undergraduate assistants. Support for the Development Core includes
management of the large IPR Seed Grant Program and management of the new Rapid Response Grants and
Generative Workshops. Additionally, the Administrative Core provides all administrative services for the IPR
speaker series (weekly seminar, annual lecture), the Grant-Writing Workshop, and the set of workshops under
the new initiative Transparent and Reproducible Research in Team Science. Further, the Grants Manager is
available to assist with development of external awards for population science research. Apart from direct
support to the Development Core, the Administrative Core: maintains the IPR Information System; produces
progress reports; assists in dissemination of research findings; communicates with IPR affiliates and the wider
OSU community; and manages IPR's 7325-square-feet suite of offices. Finally, the Administrative Core is
responsible for assisting IPR affiliates with compliance with research regulations.
This core is crucial to the success of IPR as an interdisciplinary population science research center – virtually
all IPR's efforts to nurture population science research at Ohio State University rest on an administrative
foundation. The interdisciplinary character of IPR makes certain administrative functions especially important:
the IPR Seed Grant Program and the new program of Rapid Response Grants must be widely publicized and
conducted in a manner that is regarded as open and fair; events such as the IPR Seminar must be
communicated effectively across campus; those persons pursuing population science research at OSU must
be aware of the availability of IPR services; and regular activities, such as the IPR Seminar and workshops
under the new Transparent and Reproducible Research in Team Science, must be well-managed so that
participants feel engagement with IPR is a good use of their time. In addition, thorough and rigorously-
structured documentation of IPR activities and accomplishments via the IPR Information System is essential
for presenting IPR to others (e.g. annual reports) and conducting ongoing evaluation.
Going forward, the main impetus for growth and elaboration of this core will be the three new initiatives under
the Development Core. Furthermore, with confidence it can be assumed that procedures for accomplishing
routine administrative tasks will inexorably evolve over the five-year award period.

Public health relevance
Narrative-none needed